Identifying the multi-modal factors that determine individual response to tDCS

PROJECT SUMMARY
Transcranial direct current stimulation (tDCS) has clear translational potential for a wide range of clinical
conditions, from post-stroke recovery to psychiatric and neurodevelopmental conditions. TDCS is a portable
and relatively inexpensive form of neuromodulation, with an outstanding safety profile. However, the
mechanisms underlying the effects of tDCS on brain and behavior have yet to be clarified, and relatively few
studies acquire neuroimaging data during and/or after tDCS administration. We have acquired a substantial
database (>225 sessions in >105 unique participants) of concurrent tDCS-functional MRI (fMRI) data targeting
different cerebellar subregions, with cognitive and behavioral baseline measures, post-tDCS resting state and
task fMRI, task performance data, and tDCS symptom ratings. The cerebellum interconnects with all major
cortical networks, including the prefrontal cortex, and we and others have shown that targeted cerebellar
neuromodulation can alter performance on a broad range of tasks (language, working memory, face
recognition) and in different clinical populations (aphasia, autism, schizophrenia). That said, it is clear that
there are individual differences in response to tDCS – while some participants have a robust improvement in
performance, others show decreased performance or no measurable behavioral change. Multiple factors could
drive these individual differences, including baseline task performance, resting-state brain connectivity,
idiosyncratic task activation patterns, and anatomical targeting of the neuromodulation, to name a few.
However, we do not know which (if any) of these factors are the most robust predictors of individual response.
Our goal is to apply state-of-art machine learning algorithms to this unique, multimodal dataset to determine
which factor(s) explain an individual’s response to tDCS. First, we will use individual participant’s structural
MRI scans to model the peak electric field on a participant-by-participant basis. We will use these models and
during-tDCS functional MRI data to determine the individual anatomical targeting of tDCS. Next, we will
calculate the behavioral and neural effects of tDCS based on in-scanner task performance and activation
patterns. We will extract metrics of baseline and post-tDCS resting-state connectivity in each participant. Then,
we will use the curated dataset (electric field maps, cognitive performance, age, sex, resting state data, task
activation, etc.) to determine which variables best predict the direction and size of the post-tDCS behavioral
shift. While it has been hypothesized that anatomical targeting is a critical factor in individual response, it is
also possible that baseline neural activation or even baseline task performance are the most predictive
features. These are critical outstanding questions that, if answered, will accelerate the field toward more
effective, better designed clinical trials. From a basic science perspective, this work will inform our
understanding of how tDCS impacts both brain and behavior. Our goal is to conduct work that will transform
the therapeutic efficacy of tDCS for neurological, psychiatric and developmental conditions.

Public health relevance
PROJECT NARRATIVE Neuromodulation with transcranial direct current stimulation (tDCS) has the potential to translate into novel treatment approaches for a wide range of clinical conditions, but to optimize clinical trials we need fundamental information on the poorly-understood effects of tDCS on both brain and behavior. We will apply machine learning to an extensive, rich dataset including pre-tDCS baseline measures, during- and post-tDCS neuroimaging (structural, resting-state functional connectivity, and task-evoked neuroactivation) and post-tDCS behavioral outcomes to determine the significant predictors of an individual’s response to tDCS. This project will lay the critical foundation for understanding the mechanism(s) of individual tDCS response and inform future clinical trials using this promising neuromodulation approach.